Organ donor circadian clocks in transplantation acceptance

SUMMARY
Circadian rhythms are daily variations in biological function that adapt physiology to the earth’s day-night
cycle18, 19. They arise from a hierarchal system consisting of a master pacemaker in the CNS that synchronizes
autonomous circadian “clocks” found within all nucleated cells20, 104. Mounting evidence indicates the circadian
system is important to medical interventions18, 19, 29. One reason for this is that circadian clocks temporally
organize basic immune processes 2, 31, 32. Another reason is that circadian clocks regulate cellular defenses to
metabolic and oxidative stress as occurs during ischemia-reperfusion injury46-49. Together, clock control of
immunity and ischemic responses have implications for solid organ transplantation4-7, 105, 106. There is clinical
evidence that the risk of solid organ graft dysfunction varies with the time of surgery4-7. However, prior studies
of biological rhythms in transplantation do not examine biological mechanisms and focus almost exclusively on
the transplant recipient. In this application, we show that brain-dead organ donors frequently exhibit rhythms in
core body temperature and cortisol. They also exhibit functioning circadian clocks in transplantable organs like
the lungs. Moreover, data in mice suggest that donor clocks and recipient clocks both are important for organ
acceptance. Deleting the master clock gene Bmal1 in transplanted lungs or lung graft recipients exacerbates
primary graft dysfunction (PGD), a form of ischemic lung injury. Finally, data suggest a pathway for these
effects involving clock control of neutrophil glycolysis, which in turn regulates neutrophil extracellular trap
(NET) formation. The goal of this proposal is to characterize circadian rhythms in organ donors and to identify
mechanisms by which clocks in organ donors and recipients affect transplant acceptance. We focus here on
the lung since long-term survival after lung transplantation remains poor (median of about 5 years9), and needs
new approaches. Aim 1 will generate an atlas of brain-dead organ donors' biological rhythms and circadian
clock function. It will also develop a spot assay to infer circadian clock time and robustness in donors. These
experiments leverage a unique collaboration with Mid-America Transplant Services (MTS), a high-volume
regional organ procurement organization in our area. Aim 2 will examine how the regulation of donor
neutrophil glycolysis by master clock gene Bmal1 contributes to lung PGD. This Aim will employ an established
mouse orthotopic lung transplant model to induce PGD in the presence or absence of Bmal1 or circadian clock
disruption via chronic jet lag. Together, these two independent but complementary Aims will pioneer the study
of biological rhythms in organ donors. It will characterize a novel immune-metabolic mechanism with the
potential to improve transplanted organ acceptance. It directly answers NIH research priorities described in
NOT-HL-22-043: Basic and Translational Research on Circadian Regulation of Heart, Lung, Blood, and Sleep
Disorders.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to examine circadian rhythms in organ transplant donors and how they might affect the success of transplantation. Because circadian rhythms regulate the immune system and the capacity of organs to tolerate stress, there may be preferable times of day to procure organs or perform transplantations to maximize outcomes for recipients. The practical application of these data would be in the timing of the procurement process, and the judicious dosing of drugs like steroids to optimize the quality of donated organs, thereby improving transplant success.